A Randomized Controlled Trial of MISSION-CJ for Justice-Involved Homeless Veterans with Co-Occurring Substance Use and Mental Health

Background: Among the 146,000 Veterans released from correctional settings annually, approximately 60%
have a co-occurring mental health and substance use disorder (COD). These individuals often access
treatment inconsistently, resulting in increased antisocial activities and acceleration into unemployment and
homelessness – strong predictors of reoffending. VHA Mental Health Residential Rehabilitation Treatment
Programs (MH RRTPs) commonly serve justice-involved Veterans (JIVs) with an estimated 50% annually. JIVs
receive assistance with their addiction and behavioral health needs, but MH RRTP programs do not directly
address their antisocial behaviors and cognitions. Furthermore, MH RRTP discharge is a vulnerable transition
and no national transitional approach facilitates Veteran engagement in prosocial community behaviors that
maintain MH RRTP gains, and ultimately reducing revolving door service use. Maintaining Independence and
Sobriety through Systems Integration, Outreach, and Networking-Criminal Justice version (MISSION-CJ) is a
new case manager and peer delivered team-based treatment for JIVs with a COD. Three recent open pilots of
MISSION-CJ showed reduced criminal recidivism, improved behavioral health outcomes and increased access
and engagement in care. A randomized controlled trial (RCT) is a critical next step prior to dissemination.
Significance/Impact: This application is responsive to the VHA MISSION Act, Veteran Care Priorities of
Access to Care, Mental Health, and Health Equity. The project aims to (a) increase access and engagement in
VHA and community-based care, (b) offer timely Veteran-centered care, and (c) improve the health and well-
being of JIVs while reducing disparities. It also includes an implementation aim to support VHA learning.
Innovation: While MISSION-CJ derives in part from an evidence-based treatment for homeless individuals
(MISSION), it includes a new conceptual framework and numerous new and differentiating features for a CJ
population including: (1) a treatment planning tool focused on criminogenic needs that monitors progress and
tunes service delivery elements, (2) a prosocial treatment curriculum, and (3) tools/resources to address
Veteran legal issues. With MISSION-CJ, this study attempts to change the practice paradigm and transform
care for JIVs by moving beyond the current model of linking Veterans to VA care and tracking behavioral
health outcomes, to a hybrid treatment/linkage approach that addresses criminogenic needs, supports
engagement in VA and non-VA care, and targets recidivism as an outcome–the gold standard for CJ research.
Specific Aims: Aim 1: An RCT will compare MISSION-CJ to EUC. We predict that those in MISSION-CJ will
have (1a) lower criminal recidivism; (1b) lower overall risk for criminal recidivism; (1c) better health-related
outcomes (substance use, mental health, housing, employment); and (1d) the effects of MISSION-CJ on 1a,
1b and 1c, will be mediated by (i) reductions antisocial attitudes, (ii) reductions in affiliations with antisocial
peers and increases in affiliations with prosocial peers, (iii) greater treatment engagement (i.e., MH RRTP
completion; substance use/mental health continuing care; 12-step group attendance), and (iv) increased
community reintegration. Aim 2: A formative evaluation will identify barriers and facilitators to future
implementation of MISSION-CJ in other MH RRTPs nationally.
Methodology: This project will use a Hybrid Type 1 design. First, we will test the effectiveness of MISSION-
CJ in a two-site RCT (Bedford and Palo Alto VAs) with 226 Veterans with a COD, admitted to an MH RRTP,
and previously arrested and charged and/or released from incarceration in the past 12 months. Next, we will
use the Reach, Effectiveness, Adoption, Implementation & Maintenance framework to conduct a formative
evaluation with 7 providers and 12 Veterans at each site to inform future MISSION-CJ implementation.
Next Steps/Implementation: Depending on the results of this study, we will work with our VACO operational
partners and two HSR&D Centers of Innovation to conduct a large multisite implementation trial.

Public health relevance
Criminal justice involvement and recidivism are highly prevalent among Veterans and important social determinants of health. Few treatment options with demonstrated effectiveness are available for Justice- Involved Veterans (JIVs). New comprehensive treatments such as Maintaining Independence and Sobriety Through Systems Integration, Outreach, and Networking-Criminal Justice Edition (MISSION-CJ) are emerging and aim to reduce criminal recidivism, improve treatment access and engagement and address other health- related risk factors underlying recidivism (i.e., substance use, mental health, housing, and employment problems). This study will be run in Mental Health Residential Rehabilitation Treatment Programs, and intends to compare MISSION-CJ versus Enhanced Usual Care, the latter of which includes a structured peer support curriculum as well as community outreach and linkage support. The long-term goal is to help the VA reduce criminal recidivism among JIVs, and improve the long-term health of this vulnerable Veteran population.